CENTER FOR MOLECULAR MODELING &COMPUTATIONAL CHEMISTRY

Description: Support is requested to create a Center for Molecular Modeling and Computational Chemistry (CMMCC) at UPRRP to provide the necessary infrastructure to continue to develop the research efforts and interests of the faculty.